Remote Data Enclave Core

Project Summary
The overarching goal of the Remote Data Enclave Core (Core F) of the Michigan Center on the Demography of
Aging (MiCDA) is to advance research on the demography of aging by sharing restricted data from studies
funded by the National Institute on Aging (NIA). In the coming cycle, this core will continue to oversee the secure
MiCDA virtual data enclave, which provides study-partner-approved researchers with secure access to restricted
data from specified remote locations at no charge. Study partners currently include the largest and longest
running National Institute on Aging (NIA)-funded panel studies: the Health and Retirement Study (HRS), the
Panel Study of Income Dynamics (PSID), and the National Health and Aging Trends Study/National Study of
Caregiving (NHATS/NSOC). In the coming cycle, Core F will continue to provide secure, virtual access to
restricted data through the MiCDA enclave by: adding new data from existing study partners, exploring new
partnership opportunities and broadening contextual holdings in its Geographic Linkages Repository; regularly
reviewing and upgrading hardware and software infrastructure and monitoring capacity; investigating and
remedying barriers that may unintentionally impede access to the MICDA enclave and launching a stipend
program to attract new researchers; and adding capacity to expand use of machine learning and deep learning
models in the MiCDA enclave. Core F will also collaborate with Core A on tracking, analyzing and reporting
outcomes.